Endocannabinoid Modulation of the Habenular Stress Response

PROJECT SUMMARY
Stress is a pervasive aspect of daily life and a significant risk factor for a host of mental illnesses, including
major depression. In the brain, chronic stress causes adaptations in the mesolimbic dopamine system that
increase vulnerability for developing depression and depression-related behaviors in clinical populations and
preclinical animal models, respectively. One area of the brain that has gained attention as of late is the lateral
habenula (LHb), in part because of its ability to tightly constrain dopamine activity. Notably, the LHb is
hyperactive in individuals suffering from major depression, while restoring normal activity in this area has
emerged as a viable therapeutic strategy in treatment-resistant patients. Although we still do not know how
chronic stress leads to LHb dysfunction, one intriguing possibility is through stress-induced alterations in the
endogenous cannabinoid (ECB) system. The primary role of the ECB system in the brain is to provide activity-
dependent, on-demand negative feedback, which helps to maintain synaptic homeostasis. Our data indicate
that chronic stress augments ECB signaling in the LHb, while local activation of this system elicits a passive-
despair-like coping strategy, impairs behavioral flexibility in an attentional set-shifting task, and decreases the
firing rate of dopamine neurons located in the ventral tegmental area. However, the precise role of the ECB
system in the LHb and the mechanisms by which this system modulates stress-related behaviors has yet to be
formally evaluated. In the current proposal, we will fill this important gap in knowledge by systematically
examining how the ECB system modulates LHb function and identifying whether chronic stress-induced
alterations in this system are necessary to produce deficits in dopamine cell firing and the expression of
depression-related behaviors. In Aim 1, we will perform site-specific pharmacological manipulations of the
ECB system in tandem with in vivo electrophysiology recordings of dopamine cell activity in freely behaving
rats to uncover how stress-induced alterations in LHb ECB signaling may contribute to deficits in behavioral
flexibility. In Aim 2, we will use ex vivo electrophysiology combined with retrograde labeling of LHb projections
to identify the role of the ECB system in modulating excitatory and inhibitory LHb inputs and examine how
chronic stress alters ECB control of synaptic strength at projectionally defined LHb synapses. In Aim 3, we will
use a combinatorial viral approach to determine effects of acute, circuit-specific activation of LHb neurons on
stress coping and behavioral flexibility, and test whether chronic, long-term LHb activation recapitulates the
behavioral effects of chronic stress in an ECB-dependent manner. Broadly stated, the proposed research will
fill a significant gap in the field by identifying how the ECB system regulates the activity of a key circuit that has
been implicated in various domains of mental health, and the neurophysiological and behavioral consequences
of stress-induced alterations in this system. Moreover, this work will pave the way for future studies exploring
the involvement of this system in brain function and disease.

Public health relevance
PROJECT NARRATIVE The societal and economic burden of stress-related mental disorders is currently at an all-time high. As such, there is specific urgency to better understand how the brain is changed under conditions of stress and how these adaptations contribute to the onset of cognitive deficits. In this proposal, we will identify how chronic stress alters the endogenous cannabinoid system in the lateral habenula, and determine whether stress- induced changes to this system are necessary to cause impairments in dopamine activity and behavioral flexibility.